Local immunomodulation using a microneedle patch for the management of skin transplant

ABSTRACT
Skin allograft transplantation is a lifesaving approach for the management of severe burn patients when skin
autografts or artificial substitutes are not available due to the severity of the wound. However, their ultimate
rejection increases patient morbidity and mortality and requires regrafting. Clinically-used systemic
immunosuppression, while useful in other organ transplants, cannot be prescribed for this patient cohort as they
present a high risk of life-threatening infections. Therefore, new strategies that can generate donor-specific
tolerance, while preserving other protective immune functions through local immunoregulation, are needed. We
recently demonstrated that hydrogel-based microneedle (MN) patches can be used to promote proliferation of
regulatory T cells (Tregs) in skin allografts, by locally delivering immunomodulators (CCL22 and IL-2) at the
transplant site. The MNs also facilitate the monitoring of the Treg homing process via skin interstitial fluid (ISF)
sampling (Artzi, azzi, et al, Advanced Materials, 2021). Here, we will develop a novel family of hydrogel-based
MNs that will be chemically functionalized to tailor the release kinetic profile of the immunomodulators to identify
the optimal Treg recruitment to the allograft to sustain a local, immunosuppressive effect and to restore allo-
tolerance. We will study the immunomodulatory role of the top CCL22/IL-2-doped MN platform in
prolonging long-term skin allograft while providing mechanistic insight into the biological processes
driving local immune regulation and Treg homeostasis in the allograft via ISF sampling in both an
immunocompetent- and a humanized-skin transplant murine model. Specifically, we aim to define the
optimal dose of CCL22 and IL-2 needed to maximize Treg recruitment and Treg proliferation respectively, and to
assess the role of supplementary cytokines such as IL-7 in supporting Treg homeostasis (based on our previous
data, Azzi et al, Science Translational Medicine, 2020) when co-delivered with our MN platform. Moreover, we
will gain mechanistic insight into Treg stability, function and alloantigen specificity following MN-based therapy
using a transgenic mouse model, which allows tracing the genetic lineage of Tregs. Also, we will validate the
diagnostic ability of the MN-platform for in situ monitoring of the response to therapy. Finally, we will test the
therapeutic and diagnostic merit of the MN platform in a humanized mouse model when delivering the optimal
therapeutic combination of cytokines/chemokines and its capacity to induce long-term allograft survival. Our
study will provide the foundation to develop safer technologies for enhancing skin transplant survival in a local,
minimally-invasive way without compromising the regulatory arm of the immune system of burn patients while
offering an opportunity to continuously monitor the response to the therapy.

Public health relevance
NARRATIVE: The proposed research aims to design a novel library of hydrogel-based microneedle (MN) patch for local release of immune modulators to prolong skin allograft survival in severe burn patients, by attracting regulatory T cells to the allograft and restoring allo-tolerance. Engineered MNs with varied formulations will enable identifying the release kinetics profile of the immune modulators that facilitates maximal regulatory T cell recruitment to enhance the therapeutic efficacy. We will study the immunomodulatory role of our platform, in an immunocompetent and in humanized skin transplant murine model, with respect to Treg stability, function, and alloantigen specificity when delivering CCL22, IL-2 and IL-7, and will validate its capacity to induce long-term allograft survival as well as to monitor the response to the therapy via skin interstitial fluid sampling following patch retrieval.